Functions of the Human OST-alpha and OST-beta proteins

DESCRIPTION (provided by applicant): The objectives of this application are to advance understanding of mechanisms of disposition of the two major classes of cholesterol metabolites, namely bile acids and steroid conjugates, compounds that play important roles in a number of biological processes and human diseases. The background to this proposal is our demonstration that the organic solute transporter, Ostα-Ostβ, plays a central role in mediating the disposition of these compounds. Ostα-Ostβ is an unusual heteromeric transporter that is expressed in nearly all tissues, but is most abundant in the small intestine, kidney, liver, testis, adrenal gland, as well as other steroidogenic tissues. Our studies to date of the transporter's substrate specificity, transport mechanism, tissue distribution, subcellular localization, transcriptional regulation, as well as the phenotype of our recently characterized Ostα- deficient mice suggest that Ostα-Ostβ is the major basolateral membrane exporter of bile acids and structurally related molecules. In particular, studies with Ostα-deficient mice revealed that these animals have a markedly diminished bile acid pool size, a defect in intestinal bile acid absorption, intestinal hypertrophy, growth retardation, and a decrease in serum cholesterol and triglyceride levels. Because the enterohepatic circulation of bile acids is essential for processes such as intestinal absorption of dietary fats and vitamins, cholesterol homeostasis, bile flow, and biliary lipid secretion, these data suggest that Ostα-Ostβ also indirectly regulates lipid homeostasis. The goals of this proposal are to test two hypotheses: first, that Ostβ is both a chaperone and a structural component of the functional Ostα-Ostβ transporter; and second, that the Ostα-Ostβ-mediated transport of bile acids and related steroids modulates lipid homeostasis. The specific aims are: (1) Identify specific amino acid residues of Ostβ that are critical for heterodimerization, trafficking, and/or functional activity; and (2) Examine whether Ostα-/- mice are resistant to age related, dietary, or genetically induced obesity. Overall, these studies will provide important information on the mechanism by which Ostα-Ostβ mediates bile acid and steroid disposition, on the potential contribution of the transporter to lipid homeostasis, and will provide structure-function information that should facilitate the development of therapeutics targeting this transporter. PUBLIC HEALTH RELEVANCE: Our recent studies have provided strong evidence that the organic solute transporter, Ostα-Ostβ, plays a central role in mediating the disposition of bile acids and steroid conjugates, compounds that play important roles in a number of biological processes and human diseases, including cholestatic and fatty liver diseases, malabsorption syndrome, and cholelithiasis. The goals of this proposal are to test the hypotheses that Ostβ is both a chaperone and a structural component of the functional Ostα-Ostβ transporter, and that the Ostα-Ostβ- mediated transport of bile acids and related molecules modulates lipid homeostasis. Overall, the proposed studies will provide important information on the mechanism by which Ostα-Ostβ mediates bile acid and steroid disposition, on the potential contribution of the transporter to lipid homeostasis, and will provide structure- function information that should facilitate the development of therapeutics targeting this transporter. Such therapeutics could be of benefit in many human conditions related to imbalances in bile acid or lipid homeostasis.

Public health relevance
HUMAN HEALTH SIGNIFICANCE Our recent studies have provided strong evidence that the organic solute transporter, Ostα-Ostβ, plays a central role in mediating the disposition of bile acids and steroid conjugates, compounds that play important roles in a number of biological processes and human diseases, including cholestatic and fatty liver diseases, malabsorption syndrome, and cholelithiasis. The goals of this proposal are to test the hypotheses that Ostβ is both a chaperone and a structural component of the functional Ostα-Ostβ transporter, and that the Ostα-Ostβ- mediated transport of bile acids and related molecules modulates lipid homeostasis. Overall, the proposed studies will provide important information on the mechanism by which Ostα-Ostβ mediates bile acid and steroid disposition, on the potential contribution of the transporter to lipid homeostasis, and will provide structure- function information that should facilitate the development of therapeutics targeting this transporter. Such therapeutics could be of benefit in many human conditions related to imbalances in bile acid or lipid homeostasis.